Understanding the contributions of microbiome-encoded drug metabolizing enzymes

Project Summary
Drug metabolites can have distinct efficacy and toxicity profiles relative to the parent compound, and
interpersonal variation in drug metabolism can determine adverse reactions. Notably, oral drugs that exhibit
low bioavailability, are delivered in delayed release formulations, or are excreted through bile can encounter
enormous densities of bacteria in the gastrointestinal tract. The gut microbiome carries a collective gene
content 150-fold larger than the human genome, encodes a rich repository of enzymes with the potential
capacity to metabolize drugs, and varies widely between individuals. The microbiome thus has the potential to
impact serum drug and metabolite exposure. However, scalable in vitro systems for identification of active
microbial species, enzymes, and candidate drug metabolites are not available. Our understanding of
microbiome-mediated drug metabolism is largely limited to anecdotal examples, and it is unknown whether gut
microbes encode enzymes that metabolize many drugs. Strategies for determining the quantitative contribution
of gut microbial drug metabolism to serum drug and metabolite exposure are also not available.
We developed high-throughput approaches that generate metabolomic time-series profiles of the metabolism
of hundreds of drugs by hundreds of human gut microbial communities and species, uncover the microbiome-
encoded enzymes responsible for these transformations, and identify candidate drug metabolites produced as
a result. We also provide evidence that combining gnotobiotics with physiologically-based pharmacokinetic
modeling can quantitatively disentangle host and microbial contributions to serum drug metabolite exposure in
vivo, using a drug that is converted into a single metabolite by host and microbiome as a proof of concept.
In Aim 1 of this proposal, we present a plan to establish the first repertoire of drug-metabolizing enzymes in the
human gut microbiome. These results will reveal whether human gut microbes encode enzymes that
metabolize many drugs and whether microbiome genes encoding drug-metabolizing enzymes serve as
predictive biomarkers of the drug-metabolizing capacity of an individual's microbiome. In Aim 2, we describe a
strategy to develop and test generalized host-microbiome pharmacokinetic models that capture host and
microbial conversion of a drug into multiple metabolites and include enterohepatic circulation in the model
topology. If successful, these aims will establish broadly applicable approaches to identify when and how the
microbiome could contribute to the metabolism of drugs and other small molecules.

Public health relevance
Project Narrative Most medical drugs are chemically modified (metabolized) prior to elimination, and these modified drugs can have different functions and safety concerns as compared to the original drug. Bacteria living in the gut have been implicated in the production of some of these metabolites, but we don't understand how this process occurs. This project uses experiments and computational approaches to address these questions: if successful, these studies will uncover how our gut bacteria contribute to the fate of a drug in the body.